Investigating Efficacious E-Cigarette Interventions and Cessation Effects on Cancer-Related Biomarkers: A Randomized Trial of Varenicline in Adults

ABSTRACT
Nicotine e-cigarette use in the US has increased to 13 million adult users per year. These devices are now the
most popular tobacco product among young people. E-cigarettes deliver nicotine rapidly and are highly
Harmful
emerging evidence, including work by
our team, suggests that e-cigarettes can induce DNA damage and suppress DNA repair, important
mechanisms linked to cancer.
addictive. In some devices, they can exceed the maximum nicotine delivery of combusted cigarettes.
respiratory and cardiovascular effects have also been documented and
Although many people want to quit using e-cigarettes, we currently lack
evidence-based e-cigarette cessation methods. Varenicline, the most effective monotherapy for smoking
cessation, shows promise for e-cigarette cessation including our recent 8-week preliminary trial in adults who
reported exclusive daily e-cigarette use (N=40) and either former cigarette smoking or no cigarette smoking
history. Specifically, we found that varenicline yielded numerically higher end of treatment relative risk
probabilities for e-cigarette cessation (RR=1.51) than placebo and this difference was maintained at Week 12
follow-up (RR=1.36). Thus, varenicline warrants further testing for e-cigarette cessation. In the current study,
we propose to conduct a randomized clinical trial in treatment-seeking adults (age 18+) who report exclusive
daily e-cigarette use with and without a former cigarette smoking history (N=326) to test the hypothesis that
varenicline is efficacious for quitting e-cigarettes. Specifically, we will randomly assign participants to 12-weeks
of varenicline (titrated to 2mg daily) or matching placebo and simulate a primary care model in which all
participants will receive study medication along with brief cessation advice and self-management resources.
We will achieve the following aims. For Aim 1, we will compare the effect of varenicline vs. placebo on e-
cigarette quit rates using daily smartphone EMA diaries and biochemical verification of e-cigarette use status.
For Aim 2, we will test predictors and moderators of outcomes, such as participant demographics, cigarette
smoking history, and e-cigarette device type to determine subgroups and characteristics that may impact
treatment response to varenicline. Finally, for Aim 3, we will explore changes in cancer-related biomarkers
following e-cigarette cessation treatment.
Overall, the results will provide scientific evidence on effective
treatment strategies for e-cigarette cessation and the health benefits of cessation.

Public health relevance
PUBLIC HEALTH NARRATIVE Nicotine e-cigarette use is a significant public health problem. These devices are highly addictive and harmful to the lungs and cardiovascular system, and there is emerging evidence of their potential to cause cancer. The present study will evaluate the efficacy of varenicline, the most effective smoking cessation medication, for e- cigarette cessation in adults who report exclusive use, factors that predict quitting, and changes in cancer- related biomarkers following cessation.